Upstream Regulation of Kiss1 Cells

Ovulation depends on a surge in the release of luteinizing hormone (LH), which in turn depends on a surge of gonadotropin-releasing hormone (GnRH). In recent years, kisspeptin (KISS) has emerged as the most potent stimulator of GnRH and a key regulator of reproductive development and health in vertebrates, including humans. In females, KISS signaling to GnRH cells is critical for the induction of the LH surge. Despite the central role of KISS in reproduction and specifically in female reproductive development and fertility, little is known about the upstream regulators of neurons expressing Kiss1, the gene coding for KISS. Here we present preliminary results that indicate that Kiss1 expression and the expression of c-fos within Kiss1 neurons in female mice is under circadian regulation, and this regulation is dependent on the presence of high ovarian estrogen levels. The overall goal of this proposal is to determine the pathways by which the circadian system may regulate the activity of Kiss1 neurons. Our laboratory has developed a rat model of circadian desynchronization in which independent circadian outputs are associated with the desynchronized activity of anatomically identifiable subregions of the hypothalamic suprachiasmatic nucleus (SCN), the site of the mammalian master circadian pacemaker. Our preliminary data on this forced desynchronized rat model indicates that the gating of the luteinizing hormone (LH) surge is associated with the activity of the dorsomedial (dm) SCN irrespective of the activity of the ventrolateral (vl) SCN. Because the dmSCN is the main source of vasopressinergic efferent fibers, our hypothesis is that vasopressin (VP) release is a critical SCN signal to induce the LH surge and therefore to activate Kiss1 neurons in a circadian pattern. We propose experiments that test specific predictions of this hypothesis. We will test the prediction that SCN vasopressinergic fibers innervate Kiss1-expressing cells and that innervation of the Kiss1 neuronal network by SCN efferent fibers is critical to sustain the circadian regulation of Kiss1 and of c-fos expression within Kiss1 neurons, which are concomitant with the LH surge. We will use unilateral lesions of the SCN to ipsilaterally deplete the anteroventral periventricular nucleus of SCN efferent fibers. In these animals we will assess the level of asymmetric VP innervation of Kiss1 neurons as well as the asymmetry in the circadian regulation of Kiss1 expression and c-fos expression within Kiss1 cells. Our proposed studies will characterize the pathways and mechanisms by which the activity of the Kiss1 neuronal network is regulated. Specifically, we will determine how a critical component of the mechanisms leading to ovulation such as the circadian system regulates gene expression within Kiss1 cells. Because the activity of these neurons and the release of KISS are essential for normal ovulation, understanding the upstream regulators of Kiss1 neurons will be key to developing therapies to treat disorders of the hypothalamo-pituitary-ovarian axis.

Public health relevance
According to the Department of Labor 2007 report, approximately 20 million women work irregular shifts, with at least half of these women involved in rotational shift-work full time. The female reproductive cycle affects and is affected by the circadian system. This is exemplified, in healthy humans and rodents, by the timing of ovulation, which is concentrated to the hours just before daily activity onset -early morning in humans- (for reviews on linkage between the circadian and female reproductive systems in humans see [1, 2]). Chronic exposure to shift-work negatively effects reproductive physiology, and is associated with higher rates of physical and mental disease in males and females; the proportion and nature of these ailments differs between the sexes. Indeed, female shift-workers face additional reproductive health problems [3], including painful menstruation [4, 5], increased complications in pregnancies involving miscarriages and spontaneous abortions [5-7], and potential additional strain on their mental health [8]. Internal desynchronization of the circadian system is the most salient physiological consequence of rotational shift-work. Our laboratory has been studying the regulation of ovulation in what is currently the only animal model of circadian desynchronization, and has also demonstrated that kisspeptin (KISS) -the strongest driver of the neural machinery that triggers ovulation-is under circadian regulation. Without functional KISS networks in the hypothalamus, humans and rodents fail to undergo puberty and experience hypogonadotropic hypergonadism. The main goal of this proposal is to characterize the efferent pathways emerging from the mammalian master circadian pacemaker located in the suprachiasmatic nucleus (SCN) that serve as upstream regulators of the KISS-producing neurons. Because challenges to the circadian system of women result in adverse reproductive outcomes, understanding how the circadian system regulates the female reproductive axis is critical for developing preventive practices and interventions. A better understanding of how the circadian system regulates KISS release will shed light on how circadian disruptions like shift-work lead to female reproductive disorders, providing the first framework for the development of such treatments. REFERENCES 1. Baker, F.C., and Driver, H.S. (2007). Circadian rhythms, sleep, and the menstrual cycle. Sleep Med 8, 613-622. 2. Czeisler, C.A., Rogacz, S., and Duffy, J.F. (1990). Reproductive function in women: Circadian interaction. In Ovarian secretions and Cardiovascular and Neurological Function, F. Naftolin, J.N. Gutmann, A.H. DeCherney and P.M. Sarrel, eds. (New York: Raven), pp. 239-247. 3. Costa, G. (1996). The impact of shift and night work on health. Appl Ergon 27, 9-16. 4. Colligan, M.J., Frockt, I.J., and Tasto, D.L. (1979). Frequency of sickness absence and worksite clinic visits among nurses as a function of shift. Appl Ergon 10, 79-85. 5. Uehata, T., and Sasakawa, N. (1982). The fatigue and maternity disturbances of night workwomen. J Hum Ergol (Tokyo) 11 Suppl, 465-474. 6. Axelsson, G., Rylander, R., and Molin, I. (1989). Outcome of pregnancy in relation to irregular and inconvenient work schedules. Br J Ind Med 46, 393-398. 7. Labyak, S., Lava, S., Turek, F., and Zee, P. (2002). Effects of shiftwork on sleep and menstrual function in nurses. Health Care Women Int 23, 703-714. 8. Rutenfranz, J., Knauth, P., and Angersbach, D. (1981). Shift Work Research Issues. In Biological Rhythms, Sleep and Shift Work., L.C. Johnson, W.P. Colquhoun, D.I. Tepas and M.C. Colligan, eds. (New York: SP Medical and Scientific Books).